Core C: Humoral and Serological Core

Project Summary
A major goal of this U19 is to determine how PD-1 blockade affects human antibody responses against
different viral antigens. Core C will fully interrogate serum antibody responses against a range of different
viruses from donors undergoing PD-1 therapy in Projects 1 and 2. The Core will standardize assays, complete
assays, and provide computational support for the analyses of complex serological datasets. We will offer
standardized ELISA-based services that quantify antibodies specific for 5 viruses that are relevant for Projects
1 and 2. We will also assess quality of antibody responses through ELISAs that measure relative affinities and
isotype diversity. It is possible that PD-1 blockade affects antiviral antibody responses in more subtle or global
ways. To address this, we will complete serological screens to examine how PD-1 blockade affects antibody
responses to a large fraction of known human viruses. For this, we will use a new array-based assay, termed
‘Viroscan’, that measures antibody binding to >400,000 non-redundant viral peptides. We will also offer
services that intensively analyze antibody responses against a single virus (influenza). All humans are
exposed to influenza virus in childhood and all adult encounters with influenza involve both the recall of
memory B cells and the stimulation of de novo B cell responses. Our influenza virus antigenic analyses will
allow us to determine if PD-1 blockade differentially regulates de novo versus memory antibody responses.
Together, these standardized services will allow for the complete antigenic characterization of serum samples
for Projects 1 and 2.